Impact of cesarean section on the epigenetic and transcriptional state of the maternal brain

PROJECT SUMMARY
Nearly one in three births in the United States happens via a cesarean section. Despite how common this birth
intervention is, surprisingly little is known about its long-term consequences for oxytocin system regulation and
how this relates to the wellbeing of the mother. During natural vaginal birth, oxytocin is released at high levels
during labor and delivery to facilitate uterine contractions, milk letdown, and mother-infant bonding. Cesarean
sections, particularly planned cesareans that occur without laboring, can be thought of as a birth with lower than
typical levels of endogenous oxytocin release for mothers. Recent findings have shown an association between
cesarean delivery and an increased risk for developing postpartum depression. Nearly one in five mothers will
be diagnosed with postpartum depression, a serious mental health condition that can lead to decreased quality
of life for mothers, disrupted mother-infant interactions and caregiving, and ultimately to long-term behavioral
and health consequences for children. Although postpartum depression is common among new mothers, little is
known about the potential role of oxytocin as a neurobiological risk factor. Emerging research has suggested
that for some women, changes to the oxytocin system may increase risk for postpartum depression, including
changes in circulating levels of oxytocin and epigenetic modification of the oxytocin receptor gene, OXTR. The
common link between cesarean section birth and postpartum depression risk for some women may well be
altered functioning of the oxytocin system. It may be that cesarean delivery avoids the oxytocin surge associated
with vaginal birth, resulting in an altered epigenetic state of OXTR for mothers in the early postpartum period
that may confer risk for developing postpartum depression. The primary goals of this proposal are (1) to use
single gene epigenetic methods to better understand how cesarean delivery impacts the way the oxytocin
receptor gene is regulated in the maternal brain; (2) to use whole genome sequencing techniques to examine
how cesarean section shapes expression of genes across the maternal transcriptome; (3) to study how cesarean
delivery impacts how mothers care for their offspring, how they maintain social bonds with their partner, and
whether they show more depressive behaviors after delivery; and (4) to investigate whether exposing mothers
to exogenous oxytocin just before cesarean delivery influences the consequences of a cesarean section on
these molecular and behavioral markers. The experiments in this proposal will provide valuable information on
how natural birth and cesarean section, a very common birth intervention, differentially shape development of
the maternal brain and maternal behavior, with the goal of identifying risk factors for non-optimal outcomes in
some women and, ultimately, to move toward developing interventions to counter those risk factors and improve
postnatal maternal health outcomes.

Public health relevance
PROJECT NARRATIVE The rate of birth via cesarean section has risen dramatically over the past three decades, yet little is known regarding the long-term consequences for the mother and, in particular, how cesarean delivery impacts long- term functioning of the oxytocin system. Recent evidence points to a relationship between cesarean section delivery and an increased risk for development of postpartum depression in mothers, a serious mental health issue that impacts nearly one in five mothers and is mediated in part by dysfunction of the oxytocin system, including an altered epigenetic state of the oxytocin receptor gene, OXTR. The proposed research will investigate the impact of cesarean delivery on the epigenetic and transcriptional state of the maternal brain and, in turn, its effects on expression of maternal care, depressive behavior, and social attachment, providing valuable information on how the birth experience shapes oxytocin functioning in the maternal brain and serving as a model for the role altered oxytocin functioning may play in development of postpartum depression.